Enhancing Whole Genome Sequencing Surveillance Capacity in Pennsylvania through Participation in GenomeTrakr

Project Summary/Abstract The state of Pennsylvania has been a member of the Food and Drug Administration’s GenomeTrakr network since Fall 2016, as a collaboration between Penn State and the Pennsylvania Department of Health (PADOH). This consortium successfully completed all requirements of being a member to date, while also providing training in genome sequencing and analysis to state lab members, and to undergraduate, graduate, and post-graduate students. This proposal describes the continuation of these projects for the next funding cycle, as well as expanded efforts to obtain and distribute food and agricultural isolates to other GenomeTrakr labs for whole genome sequencing.

Public health relevance
Project Narrative In Spring 2019, whole genome sequencing, also called WGS, finally replaced pulsed field gel electrophoresis as the standard molecular subtyping method in public health laboratories. This project is for the Pennsylvania GenomeTrakr consortium to continue assisting the United States Food and Drug Administration with their goals of populate databases with ever more genome sequences of foodborne pathogens.